PILOT PROJECTS

The Administrative Core will be responsible for the coordination of the SCOR grant including integration of the separate Projects and the financial management of the grant. The unique responsibilities of the Administrative Core include support for the Internal and External Scientific Advisory Boards including yearly evaluations of the SCOR projects and the bin-annually evaluation of the new investigators Pilot Project applications, accurate record keeping, and required reports to years at $50,000/year. The purpose of the Pilot Project funding is to support promising junior investigators until their receive their first NIH funding as Principal Investigators.